Functional characterizations of the genetic etiology of stuttering

ABSTRACT
Developmental stuttering is a common speech disorder characterized by prolongations, blocks, and repetitions
of speech sounds. Studies of developmental stuttering within twin, family, and population isolates suggest a
strong genetic influence on stuttering risk with heritability estimates ranging from 0.42 to 0.84. Population-wide
studies suggest that stuttering genetic risk factors are complex and involve both familial and population-level
variation. In the largest genome-wide association study (GWAS) of stuttering, we identified 57 unique genome-
wide significant loci associated with self-reported stuttering risk. Despite these population and familial efforts,
the functional role that genetic variation contributes to stuttering risk remains largely uncharacterized. The current
work proposes to use extant self-report stuttering GWAS results and newly genotyped and sequenced whole-
exome data to better understand the biological mechanisms contributing to stuttering risk. Aim 1 will explore
the genetically regulated gene expression associated with self-reported stuttering by leveraging GWAS
summary statistics in over 1.1 million cases and controls. We will perform sex- and ancestry-specific
transcriptome-wide association analyses using Joint-Tissue Imputation, prioritizing brain and neuromuscular
tissues. We will assess consistency and generalizability of the genetically regulated gene expression associated
with self-reported stuttering in independent sex- and ancestry- specific analyses in two independent cohorts -
the International Stuttering Project and the Adolescent Health study. To explore the role of rare functional
variation, Aim 2 will pinpoint familial genetic effects of developmental stuttering. Using array and whole-
exome sequenced data collected in over 200 families, we will perform a novel polygenic risk-adjusted multipoint
linkage analysis approach, conduct transmission disequilibrium tests, apply a pedigree variant annotation
analysis search tool (pVAAST), and meta-analyze rare and common gene-based results developed in Aim 1.
Aim 3 will identify neural endophenotypes related to stuttering-associated genes. We will utilize a newly
developed tool, NeuroimaGene, to assess the genetic relationship between stuttering associated genes from
Aims 1, 2, and the literature with neural endophenotypes measured in more than 33,000 people in the
UKBiobank. Results from Aim 3 will illuminate specific neural mechanisms contributing to stuttering risk via
genetic mechanisms and will be compared to results from the literature on brain imaging in people who stutter.
Together, these aims will characterize functional relationships contributing to stuttering risk, better inform our
understanding of stuttering, as well as potentially inform clinical and therapeutic practices.

Public health relevance
PROJECT NARRATIVE Developmental stuttering affects 5% of children and 1% of adults worldwide, and exhibits a sibling relative risk of 70%; however, despite this high population prevalence and remarkably high heritability, understanding of the molecular and neurological function of genes impacting stuttering risk is lacking. The present application proposes to enhance our understanding of how common and rare genetic factors contribute to stuttering by using information about how genes are transcribed and how gene transcription affects brain features. This study represents the largest and most comprehensive functional genetic analysis of stuttering ever performed and the results obtained in this study will be critical to improving basic understanding of the mechanisms that contribute to risk, providing a foundational first step for future studies and therapeutic strategies.